An engineered prodrug for inhibition of cancer growth and metastasis

Treatments for metastatic and recurrent solid tumors, including ovarian, lung and colon cancers, remain a
challenge due to lack of potent, selective and effective therapeutics. Clinically approved chemotherapies aim to
slow or stop tumor growth; however, cancer cells continue to evolve between chemotherapy cycles, acquiring
properties that allow cell survival and successful dissemination, subsequently developing into life-threatening
metastatic tumors. There is an urgent need to develop more effective therapeutic strategies based on the biology
of metastatic tumors to achieve long-term remission. We are developing the basis for a transformative anti-
cancer strategy based on drug delivery by anthrax toxin (AT) proteins engineered to be selectively activated by
the catalytic power of dysregulated zymogen-activating proteases on the surface of malignant tumor cells.
Specifically, we are leveraging tumor-associated hyperactive membrane-anchored serine proteases (MASPs) to
selectively deliver potent cytotoxins that inactivate signaling pathways used by tumors for survival and
chemotherapy resistance. We are applying this novel anti-tumor strategy to serous ovarian cancer (OC), a deadly
disease which presents in many different molecular and pathological subtypes that complicate rational drug
treatment and design. Current clinical management is primarily based on maximal cytoreductive surgery and
combination carboplatin-paclitaxel (CPTX) chemotherapy. While targeted therapies have shown some
improvements, they have failed to increase the overall survival rate. A high rate of recurrence following the initial
treatment has been observed with patients presenting with metastatic tumors that respond poorly to
chemotherapy. We have developed a prototype AT prodrug (PAS) that has been re-engineered to be specifically
activated by deregulated MASPs on tumor cells, and which, in combination with the cargo lethal factor (LF),
delivers potent and selective anti-tumor cytotoxicity. Preliminary data demonstrate that the engineered PAS:LF
is a tumor-selective and potent cytotoxic agent that is without side effects at effective therapeutic doses. Notably,
we find that exposure of OC cells to CPTX chemotherapy increases tumor-associated MASP cell surface activity
and stimulates MAPK prosurvival pathways, which together inadvertently increases metastatic potential, but
serendipitously also serves to enhance the efficacy of PAS:LF for tumors exposed to CPTX. The hypothesis to
be tested in this proposal is that leveraging hyperactive MASPs on the tumor cell surface to deliver potent
cytotoxins selectively into cancer cells using PAS:LF is an effective strategy to target tumor cells and enhance
sensitivity to CPTX. The experimental plan proposes to 1) define mechanisms of PAS:LF and other ZMT:LFn
drug actions in the absence and presence of CPTX, and 2) determine the efficacy, pharmacokinetic and
pharmacodynamic properties of combination of standard-of care CPTX plus PAS:LF for treating high grade OC
in preclinical models. This new class of drugs are strong candidates for therapeutic development to improve the
prognosis for women with OC, and other solid tumors.

Public health relevance
There is a significant unmet need for more effective targeted therapies aimed at the biological properties of metastatic tumors. We propose to develop a novel anti-tumor prodrug cytotoxin that is activated specifically by zymogen-activating serine proteases on tumor cells recognized to promote tumor metastasis, and whose activities are further increased by standard of care chemotherapy. We propose to validate the mechanism of action and pharmacological properties of this biologic as a monotherapy and in combination with chemotherapy to advance its clinical application to improve the prognosis for women with malignant epithelial ovarian cancer, and other tumors.